Development of analytical methods for detecting microcystins in fish tissue

Project Summary/Abstract
Harmful algal blooms (HABs) consisting of cyanobacterial species have been increasing in waterways in the
United States and elsewhere due to the impacts of pollution and climate change. Cyanobacteria produce a
number of cyanotoxins, the most common of which are microcystin-LR and related microcystins, which are
potent hepatotoxins. Microcystins are known to bioaccumulate in aquatic organisms, some of which are part of
the human food chain. While commercial ELISA kits are available to screen water samples for microcystins
and Liquid Chromatography/Mass Spectrometry (LC/MS) methods have been developed to quantitate
microcystin in water, there has been limited research on detecting or quantitating microcystins and their
metabolites in biological matrices. Some studies have attempted to use commercial ELISA kits developed to
screen water samples to screen samples of fish meat, but these methods have not been thoroughly validated.
We will develop and validate a robust quantitative LC/MS method to quantitate microcystin in fish, other animal
tissues, to be used for veterinary diagnostic investigation and food safety assurance. This method will be used
to validate the rapid ELISA-based screening method that has been developed Todd Miller at the University of
Wisconsin, Milwaukee.

Public health relevance
Project Narrative We will develop a method using High Performance Liquid Chromatography and Mass Spectroscopy (LC-MS) to detect the important cyanotoxin, microcystin-LS and related congeners, in fish tissue, animal tissue, and other food, feed, and diagnostic samples to assure food safety and improve veterinary diagnostic investigation of cyanobacterial poisoning cases. The LC-MS method will be used to assess an ELISA test-kit based screening method that was developed by Dr. Todd Miller at the University of Wisconsin, Milwaukee, to quantitate microcystins in fish tissues. Once validated, these analytical methods will be made available to toxicology laboratories in the Vet-LIRN network as a tool for screening foods and feeds and for veterinary diagnostic investigations.